REACH-SPIROMICS: Research on Environmental Aeroallergens, COPD, and Health in SPIROMICS

SUMMARY/ABSTRACT
Exposures to pollen and other ambient aeroallergens are well-established drivers of allergic rhinitis and
asthma, but their role in Chronic Obstructive Pulmonary Disease (COPD) is largely unknown. A lack of
aeroallergen monitoring data has contributed to limited research in this area, despite expanding aeroallergen
levels associated with climate change. Monitoring technology for aeroallergens is advancing rapidly based on
image analysis using artificial intelligence (AI), providing an opportunity to measure aeroallergen
concentrations in near-real time and at multiple-locations. Our overall objective is to determine the impact of
short- and long-term aeroallergen exposure on COPD outcomes and to ascertain whether allergic phenotypes
among those with COPD—including blood eosinophil count, aeroallergen sensitization, sputum characteristics
and airway transcriptomics—alter susceptibility to adverse health effects of aeroallergens. We leverage the
SPIROMICS and SOURCE cohorts that comprise uniquely phenotyped, prospectively characterized
participants with COPD or at high risk for developing COPD. We will develop taxa-specific estimates of daily
and seasonal aeroallergen concentrations at individual home addresses using existing data from the nearest
National Allergy Bureau (NAB) aeroallergen counting station (between-city measures) and sophisticated fine-
scale, spatiotemporal models of aeroallergen concentrations (within-city measures) using advanced geospatial
exposure models that incorporate not only the historical NAB monitoring data but also high resolution
monitoring data from new aeroallergen monitors with AI-based image analysis. We will assess whether both
short- and long-term ambient aeroallergen exposures are associated with respiratory symptoms, frequency
and timing of exacerbations, lung function decline by spirometry, CT-based quantitative emphysema and small
airway abnormalities, and disease prognosis in the well-characterized SPIROMICS and SOURCE participants.
These results will provide historic and real-time pollen counts to inform risk communication, develop
personalized treatment approaches and exposure mitigation strategies for patients with COPD, and forecast
new risks due to the changing environment.

Public health relevance
PROJECT NARRATIVE Exposure to outdoor aeroallergens may be an important risk factor for chronic obstructive pulmonary disease (COPD), but a lack of aeroallergen monitoring data has contributed to limited research in this area (despite expanding aeroallergen levels associated with climate change). We propose to develop state-of-the-art models to predict ambient pollen and mold exposure at homes of SPIROMICS and SOURCE participants, and to study the short- and long-term effects of aeroallergen exposure on COPD incidence, progression and mortality. The results will be critical to understanding treatment and prevention of health effects in this vulnerable population.